The Kansas Department of Agriculture's Flexible Funding Model Cooperative Agreement for MFRPS Maintenance, FPTF, and Special Project.

Long-Term Objectives
The Kansas Department of Agriculture, Division of Food Safety and Lodging (KDA-FSL) is seeking
federal funding with the goal of maintaining continuous improvement with the Manufactured Food
Regulatory Program Standards (MFRPS) and enhancing the national, fully integrated food safety system.
KDA-FSL is also seeking funding for the continued progress of the Kansas Food Protection Task Force
(FPTF). The FPTF is composed of a diverse group of regulatory and industry stakeholders and aims to
improve food safety awareness in the state of Kansas. Through requested special project funding, KDA-
FSL seeks to improve the sampling and response capabilities of the manufactured food program.
Specific Aims
KDA-FSL seeks to further the progress of an already robust manufactured food safety program and
protect the public's health in Kansas and nationwide. It is the responsibility of KDA-FSL to reach hard-
to-reach food industry stakeholders in Kansas to educate them on new law and regulations, provide
technical assistance, and discuss emerging trends related to food safety issues. By stress-testing the
program, KDA-FSL will go beyond the MFRPS criteria to drive system improvements in the sampling
program.
Methods
KDA-FSL will maintain a strategic improvement plan (SIP) to target realistic completion dates for annual
review of program policies and procedures. KDA-FSL will fully incorporate the Preventive Controls Rule
into the manufactured food training program to ensure all inspection staff are fully trained and capable of
conducting full and limited-scope Preventive Controls for Human Food inspections. KDA-FSL will
engage the FPTF via quarterly educational newsletters and an annual food safety task force meeting.
KDA-FSL will host a full-scale training exercise centered around a positive sample from a manufactured
food firm. By involving a variety of stakeholders, KDA-FSL will produce replicable materials for FDA
and other jurisdictions to utilize to improve their own programs as part of the national, fully integrated
food safety system.

Public health relevance
Narrative By continuing to participate in the Manufactured Food Regulatory Program Standards (MFRPS), Kansas Department of Agriculture Division of Food Safety and Lodging (KDA-FSL) will strive to maintain full implementation and full conformance of the Standards. Maintaining progress with the MFRPS will allow KDA-FSL to continuously improve program policies and procedures to protect the public’s health and align with the 2022 MFRPS. The Food Protection Task Force (FPTF) and Special Project (SP) will serve to educate industry and regulatory stakeholders on a variety of strategies to reduce foodborne illness in the state of Kansas.